SERPINE family genes in rhabdoid tumorigenesis

Project Summary/Abstract
Malignant tumors characterized by rhabdoid features often display highly aggressive biology, frequently resulting
in fatal outcomes, even when these features are localized to small areas within the tumors. Despite their relatively
low occurrence, rhabdoid features have been observed across various tumor types and are linked with early
metastasis. Notably, clear cell renal cell carcinoma (ccRCC) with rhabdoid features represents a recently
identified histopathologic variant of renal cell carcinoma (RCC). The current management and clinical trajectory
of these tumors exhibit significant variability with limited success. Researchers face challenges in accurately
diagnosing rhabdoid features from biopsy specimens and lacking definitive data to comprehend these features
thoroughly. To uncover the molecular mechanisms and understand the role of SERPINE family genes underlying
rhabdoid tumorigenesis, Dr. Li will leverage recent advances and availabilities of the multi-omics data set and
his integrative computational and experimental approach consisting of multi-omics, spatial, histopathology, and
in situ analysis. During the K99 mentored phase of the award, Dr. Li proposes identifying the molecular
signatures and mechanisms underlying rhabdoid tumorigenesis in ccRCC (Aim 1). During the R00 independent
phase of the award, expanding on his earlier SERPINE-related findings in ccRCC, Dr. Li will apply multi-omics
technologies and functional studies to understand the role of SERPINE family genes in rhabdoid tumorigenesis
of ccRCC (Aim 2). Furthermore, Dr. Li aims to ascertain the aggressiveness and heterogeneity signatures of
advanced tumors with rhabdoid features at the broader pan-cancer level, given their presence in varied cancer
types (Aim 3). The results of this proposal have the potential to give fundamental new insight into the associated
aggressiveness signature and mechanisms underlying the rhabdoid phenotypes, which will assist the clinical
procedures for diagnosis and treatment. Notably, a better understanding of the role of SERPINE family genes in
rhabdoid tumorigenesis can potentially lead to the development of effective treatment strategies for advanced
tumors with rhabdoid features. This proposal also describes a detailed training plan to advance Dr. Li’s career
as an independent investigator, combining computational and analytical approaches on varied data types with
histopathology and experimental biology to uncover the mechanisms underlying tumorigenesis and progression
better, identify therapeutic vulnerability and predict the treatment response. Throughout the K99 phase, Dr. Li
will receive strong support from an interdisciplinary team of experts to expand his knowledge and refine his skill
set for the transition into an independent investigator.

Public health relevance
Project Narrative Malignant tumors containing rhabdoid features tend to be highly aggressive, with frequent fatal outcomes, even when the rhabdoid components are only focal and limited to small areas within the tumors. The treatment and clinical course are highly variable with little success, and it remains uncertain which factors influence treatment response and prognosis. This proposal aims to understand the aggressive signatures and the molecular mechanisms underlying rhabdoid tumorigenesis and determine the role of SERPINE family genes as potential therapeutic targets in treating advanced tumors with rhabdoid features.